Discovery of regulatory and cryptic splice-impacting variants in facial ectoderm-expressed genes: a secondary analysis of GMKF orofacial cleftdata.

PROJECT SUMMARY/ABSTRACT
This proposal centers around a secondary analysis of available whole genome sequencing data from the
Gabriella Miller Kid's First orofacial cleft cohorts. Non-syndromic orofacial clefts, such as cleft lip/palate, are
among the most common human birth defects, yet our understanding of the significant genetic component
underlying the risk of being born with this anomaly is far from complete. The proposed research plan involves a
two-pronged targeted analysis to identify genetics variants that is unique in its approach. The first aim seeks to
catalogue variants located within regulatory elements specifically active in the facial ectoderm, while the second
aim investigates deep intronic variants in ectodermally expressed genes for their potential to disrupt correct
mRNA splicing. The unique focus on ectodermal gene contributions is based on strong demonstrable biological
data for this cell population being a major contributor to orofacial cleft risk. These analyses hold the promise of
providing unique insight into the genetic architecture of non-syndromic cleft lip/palate.

Public health relevance
Narrative Cleft lip/palate is one of the most common human birth defects. The project will interrogate whole genome sequencing data from case-parent trios for genetic variation located in and around genes that are specifically expressed in the embryonic facial ectoderm which is the population of cells that mediate the closure of the lip and palate during development.